Training Program in Pharmacological Sciences

Abstract
The Training Program in Pharmacological Sciences at Stony Brook University trains Ph.D. students in the broad
area of Molecular and Cellular Pharmacology for careers in academia, government, and industry. The Program
is based in the Department of Pharmacological Sciences in the Renaissance School of Medicine at Stony Brook
University, but is interdisciplinary and interdepartmental in nature. It includes 42 potential mentors, 31 of whom
are from other (i.e., non-Pharmacological Sciences) University Departments or the nearby Cold Spring Harbor
Laboratories. Students take courses in Basic Principles and Systems Pharmacology, Biochemistry, Cell Biology,
and Experimental Methods. The Training Program provides training in quantitative research skills, scientific
communication and writing, and supports multiple career development activities, training in rigor and
reproducibility and in the responsible conduct of research. The interdisciplinary training environment includes
active seminar series and participation in research symposia, workshops, and retreats. Training also involves
teaching in courses offered to undergraduate majors in pharmacology. First year students participate in three
laboratory rotations to prepare them to undertake dissertation research in any of the laboratories of the Training
Program Faculty. The Training Program has trained more than 170 Ph.D. students in its 45-year history who
have launched successful research-intensive or research-related careers after graduation, as well as 52 highly
diverse current trainees who are on track for future career success.

Public health relevance
Program narrative The Training Program in Pharmacological Sciences provides PhD students with a comprehensive background in the discipline of Pharmacology by bringing together training faculty from different research fields involved in the discovery, development and use of therapeutic compounds, exposing students to relevant clinical problems, emphasizing translational research, and providing opportunities for students to present their research in national and international meetings. The program offers courses in Pharmacology, provides training in quantitative research skills, scientific communication and writing, and supports career development activities to ensure the success of students in subsequent research-intensive and research-related careers. The training grant supports students early during their training (1st and 2nd year), emphasizes recruitment and retention of diverse students, upholds a culture of responsible conduct in research as well as rigor and reproducibility in scientific research and has outstanding outcomes, with alumni represented in the entire spectrum of the research enterprise, leading research groups in academia and industry, defining patent law, and shaping future research policy.